Ultrafast Quantitative pH MRI for Acute Ischemic Stroke Patients

ABSTRACT
Ischemic stroke is one of the leading causes of morbidity and mortality in the U.S. The goal of acute ischemic
stroke therapy is to salvage tissue that is at risk of infarction, but still viable, through the use of reperfusion
strategies. Current reperfusion therapies are limited by a tight time window for treatment and by the potential risk
of brain hemorrhage. Using this time-based approach, only a limited number of stroke patients are eligible for
treatment. Patients who present beyond the standard treatment time windows can benefit from therapy when
identified based on multimodal MRI; however, precise and accurate identification of the salvageable tissue is
essential, as the potential beneficial effect of treatment must be weighed against the risk of hemorrhage.
Although a diffusion/perfusion MRI mismatch has been suggested as a guide with which to identify the presence
of salvageable tissues and to serve as a selection marker for thrombolysis, the results of clinical trials using this
criterion have been inconclusive, in part because of the inclusion of regions of oligemia in the penumbra, which
overestimates the size of the tissue at risk. Amide proton transfer (APT) MRI has shown promise in detecting
such an acidosis-based ischemic penumbra in animal models and in human stroke patients. However, most
currently used APT imaging protocols are not very practical and not optimized with respect to the magnitude of
signal changes caused by the pH effect. More quantitative APT-MRI typically would require an even longer scan
time due to the use of multiple RF saturation frequencies, multiple acquisitions, and a long RF saturation pulse
(or pulse train), all of which hamper clinical translation due to the very small time-window between stroke onset
and possible thrombolysis treatment. Our long-term goal is to develop an ultrafast pH imaging technique for
routine clinical use to guide reperfusion therapies for hyperacute stroke patients at various therapeutic time
windows, as well as predict the risk of hemorrhagic transformation (HT) following acute ischemic stroke. The first
clinical hypothesis is that, similar to animal studies, the pH imaging penumbra due to ischemic tissue acidosis
predicts the maximum final infarction size if no reperfusion is initiated. Our second clinical hypothesis is that the
presence of severe tissue acidosis in the ischemic core is associated with an increased probability of secondary
HT. Our hypotheses will be tested through three specific aims: 1) to develop and optimize an ultrafast quantitative
pH imaging method; 2) to validate this technique and assess the diagnostic accuracy of the acidosis-based
ischemic penumbra in a clinical setting; and 3) to develop a novel deep-learning model with which to predict HT
following acute ischemic stroke, and quantify the sensitivity and specificity of pH imaging. This work is expected
to accelerate the translation of APT-MRI into a clinically viable and robust method. The addition of pH imaging
to the standard MRI protocol is expected to enable better visualization of the true ischemic penumbra, thus
improving predictions of clinical outcome and reducing the incidence of HT.

Public health relevance
NARRATIVE This research proposal is designed to optimize the speed and evaluate the accuracy of a novel pH MRI technique for identifying stroke patients with salvageable brain regions, as well as patients at increased risk for developing hemorrhage after an acute ischemic stroke. The results would enhance patient selection for treatment, extend the therapeutic time window, and improve the risk-benefit ratio of recanalization therapies.